Multifunctional Roles of AgI/II Family Proteins

Project Summary
Streptococcal bacteria contribute to infections of vital organs through their surface proteins which facilitate their
adherence, colonization, and biofilm formation. In the oral cavity, S. mutans use its surface adhesins AgI/II and
GbpC to adhere to Gp340 for initial adherence, dextran to promote biofilm development, and in some cases
other microbes which are incorporated into biofilms. More generally many members of the streptococcal species
express an AgI/II-like homolog which they use to adhere to both shared and species-specific targets, implicating
them in contributing to the disease state of infections involving these streptococci. At sites of physical damage
to gums or gum disease, streptococcal species can infiltrate the blood stream and become systemic opportunistic
pathogens.
This proposal focuses on characterizing the molecular mechanisms of host-microbe and microbe-microbe
interactions involving the AgI/II-family of proteins. In structural studies of SspB the Deivanayagam lab discovered
a peptide-binding cleft within the V-region, a shared cleft housing a calcium ion. This peptide has nanomolar
adherence with the V-regions of SspB, AgI/II and GbpC; the peptide inhibits the V-regions adherence to SRCR
region of Gp340 and reduces biofilm formation. In studies with GbpC, this cleft was shown to also be involved in
the V-regions adherence to dextran. Our preliminary studies have shown not only shared adherence targets, but
also conserved areas of adherence.
Both the apical V-region and cell-wall anchored C-terminal regions of AgI/II-family proteins have been shown to
be involved in adherence host surfaces. In this proposal we plan to investigate the hypothesis that the
Extracellular matrix (ECM) protein interactions among AgI/II-family proteins would share similar but distinct motifs
that contribute to the initiation or progression of infections outside the oral cavity. The specific aims are Aim1:
Characterize the interactions between AgI/II-family proteins and ECMs. Aim 2: Determine AgI/II proteins’ ability
to interact with other pathogenic microorganisms. The proposed studies will elucidate shared areas of adherence
to determine the potential for designing inhibitors to prevent the interaction which would reduce the ability of
these streptococci to contribute to infection and disease.

Public health relevance
Project Narrative Streptococcal species, such as S. mutans and S. gordonii, are known to cause or contribute to infections of the oral cavity such as caries and periodontal diseases using surface proteins to adhere to tissues for colonization and infection. A streptococcal-specific set of surface proteins, the AgI/II-family, have been shown to adhere to a range of human extracellular matrix proteins, other microbes, and components of the biofilm such as dextran. Directly interrupting adhesion to these targets would offer an antibiotic-fee treatment option to prevent infections of the oral cavity as well as preventing their contribution to infections of vital organs where AgI/II proteins contribute to disease.